Fluorescence Guided Surgery using Near Infrared Nerve-specific Probes for Cranial Nerve Preservation

PROJECT SUMMARY
Iatrogenic nerve injury presents one of the most feared surgical complications and a major source of morbidity
across all surgical specialties. While crucial to maintain their vital functions, preservation of cranial nerves re-
mains a major challenge in skull base surgeries. Additionally, with the increased use of minimally invasive sur-
gical approaches, difficulty with cranial nerve identification and visualization is amplified. Cranial nerves are often
intimately associated with tumors of the skull base, where surgery can be curative, but must be balanced against
injury risk. Unlike other critical tissues (e.g., blood vessels), nerve repair produces negligible, unreliable func-
tional improvement. Permanent motor or sensory disabilities and chronic neuropathies result, limiting patient
quality of life, employability and participation in daily activities. The only known method to avoid nerve injury is
to prevent its occurrence. However, no clinically approved technology sufficiently enhances intraoperative nerve
visualization, where a combination of neuroanatomical knowledge, white light visualization and neurophysiolog-
ical monitoring are currently used. This work will directly address this unmet clinical need. Fluorescence Guided
Surgery (FGS) has successfully integrated into clinical medicine with only a few FDA-approved fluorophores
(i.e., fluorescein, Aminolevulinic/Protoporphyin IX [ALA/PpIX], methylene blue and indocyanine green [ICG]).
While FGS systems for imaging outside the skull operate almost exclusively in the near infrared (NIR, 650-900
nm), imaging system for neurosurgery are commonly equipped with the ability to image in the visible. However,
all clinical FGS systems have an “800 nm” channel designed to image ICG, including neurosurgical microscopes
and wide-field exoscopes. To facilitate clinical translation and utility for neurosurgery, the overall goal herein is
to generate a nerve-specific small molecule fluorophore with spectral properties matched to ICG. This novel
probe would enable cranial nerve visualization that is spectrally distinct from the visible fluorescein and ALA/PpIX
that are commonly used for tumor enhancement, while enabling future clinical translation using existing neuro-
surgical FGS infrastructure. Development of a NIR nerve-specific probe has presented a synthetic challenge as
molecules must be small enough to cross the tight blood nerve and/or blood brain barrier(s) (BNB and/or BBB,
respectively), but with a sufficient degree of conjugation to reach NIR wavelengths. This is a particular challenge
in neurosurgical applications where identification and visualization of structures at the interface of the peripheral
and central nervous system (PNS and CNS, respectively) are required for successful surgical outcomes. In pre-
liminary work, our group has designed and developed NIR oxazine-based probes with exquisite PNS specificity
and recently discovered that a new library of oxazine probes provide BBB-cross and CNS specificity, however
an agent suitable for clinical translation does not yet exist. Herein, we will develop NIR nerve-specific fluoro-
phore(s) for identification and visualization of the cranial nerves with and without tumor counterstain (i.e., fluo-
rescein or ALA/PpIX) in animal models of meningioma and schwannoma.

Public health relevance
PROJECT NARRATIVE Management of tumors at the skull base has been clinically challenging for over a century as they are typically located deep in the skull and are routinely associated with critical neurovascular structures, where damage leads to high morbidity and mortality. While neuroanatomical knowledge, white light visualization and neurophysiolog-ical monitoring are utilized in concert to preserve the cranial nerves, nerve damage and incomplete resection continue to challenge skull base surgeries. Intraoperative nerve-specific imaging using a cranial nerve specific fluorescent probe would significantly improve nerve identification and visualization, providing an immediate ben-efit to patients and surgeons.